Northwestern CORE Clinical Research Site: Trans-omics for HIV/AIDS Research

The Northwestern University and the Ruth M. Rothstein CORE Center of the Cook County Health & Hospitals
System Clinical Research Site (NC CRS) addresses the highest research priorities in HIV/AIDS research
through retention and maintenance of the cohort, collection and repository storage of blood samples, and
development and implementation of the unified science agenda. Through the leadership we provide and the
data and blood samples we collect, the NC CRS actively contributes to core protocols and thematic sub-
studies to characterize the long-term, natural and treated history of HIV infection in a representative cohort of
people at substantial risk of becoming infected with the virus. We strictly adhere to good practice guidelines,
established policies and procedures, and robust quality assurance and quality control measures to ensure the
accuracy, reproducibility, and integrity of the clinical and laboratory data and blood samples. Scientific and
administrative management provides both the flexibility and means to conduct multidisciplinary research
projects as well as the resources to respond rapidly to recent scientific progress. For the past 35 years, we
have maintained a comprehensive portfolio of biomedical and social science research on HIV and its related
coinfections, comorbidities, and other complications. The diversity of the work makes possible a broad and
multidisciplinary view of these high priority topics for understanding the basic biology of HIV, immune
dysfunction and chronic inflammation, and genetic determinants. Scientific questions take full advantage of the
strengths of the cohort, namely, its duration and the continuity of data and blood samples that timespan
provides. Data and blood samples are available from people before and after infection, before and after
beginning medications, or before and after the development of comorbidities or their complications. Productive
relationships across the combined cohort, as well as other consortia and organizations, have coalesced around
specific issues to advance scientific knowledge, the health of people, and policy development. By capitalizing
on the expertise and unique resources of a multidisciplinary team of experts, we will build on our studies of
genome sequence, patterns of gene and protein expression, and metabolite concentrations and changes
(trans-omics dataset), along with information from people's medical records, to identify genes and pathways
that play a role in disease and determine how they interact with HIV. Hierarchal models that predict the
network behavior that gives rise to a phenotype will unravel the complexity of disease to provide novel and
important insights into biological processes for testing or generating a set of hypotheses about disease
mechanisms. During the next 7-year funding cycle, the NC CRS will continue support for the cohort and trans-
omics for HIV/AIDS research that complements and extends the NIH Precision Medicine Initiative that
connects genotype and phenotype and aligns with the NIH Big Data Initiative that supports innovative and
transformative approaches to advance understanding of human health and disease.

Public health relevance
The NC CRS is part of the longest-running prospective study of the natural and treated history of HIV infection in people at risk for becoming infected. This ongoing study chronicles biological and psychosocial factors that have shaped the epidemic, tracking HIV disease and HIV-related comorbidities. The knowledge gained regarding effects of the virus and aging on inflammation and immune dysfunction, which render some people more susceptible to HIV-related comorbidities than others, will improve the clinical care of people living with HIV/AIDS, guide public health public health policy, facilitate discovery of novel drug targets, and contribute to vaccine development.